Vaping and Smoking Cessation in Intensive Longitudinal National Data

PROJECT SUMMARY
The overall goal of this project is to determine whether vaping is associated with smoking cessation in US
adults by conducting secondary analyses that leverage a novel “intensive” longitudinal national data source
with bi-weekly survey waves. Current observational evidence of the association between vaping and smoking
cessation using national longitudinal data sources (e.g., the PATH study) may provide insufficient temporal
precision due to the long inter-survey intervals (e.g., 12-month). Long intervals are problematic because many
smokers make multiple quit attempts within a year and vacillate between abstinence and smoking. In addition,
given that smokers who try e-cigarettes are more likely to have nicotine dependence, have higher quit smoking
motivation, and have sociodemographic factors that may impact cessation, selection biases are always a
threat to observational studies examining vaping-assisted smoking cessation. Also, addressing mental health
in studies examining the prospective association of vaping with smoking cessation is crucial because quit
attempters may face anxiety, depression, and other symptoms that spike within the first several weeks of
nicotine abstinence. To address this research gap, the proposed study will leverage the nationally
representative longitudinal panel survey of the Understanding America Study, including 8,306 US adults with
26 bi-weekly survey waves (April 2020 - July 2021) and nine additional monthly follow-up surveys (October
2021 - June 2022) with past-week vaping and smoking frequency measures. Specifically, this study will use the
subsample of baseline past-week smokers (n=1154, 16.6%) to assess bi-weekly associations of time-varying
nicotine vaping with time-lagged smoking abstinences two weeks later across follow-ups extending up to 110
weeks after baseline, which will enable us to avoid insufficient temporal precision in previous national studies
of vaping-assisted smoking cessation. In addition, intensive longitudinal multi-level modeling that partitions
between- and within-subject variance to address between-person confounds will be used to test our
hypothesized model of vaping-related smoking cessation, which will also mitigate selection bias. Specific
research aims are to: (1) determine short-term (2 weeks) and long-term (up to 110 weeks) associations of daily
or non-daily (vs. no) vaping with smoking cessation; (2) determine whether anxiety/depression symptoms are a
mediator and consequence of vaping-related smoking cessation; (3) examine other substance use as a time-
varying moderator of the association of vaping with smoking cessation and the anxiety/depression mediation
pathway. The proposed study will address whether vaping encourages smokers to initiate and sustain smoking
cessation in the real world, and if they experience cessation-related mental health benefits.

Public health relevance
PROJECT NARRATIVE Current observational evidence of the association between vaping and smoking cessation using national longitudinal data sources (e.g., the PATH study) may provide insufficient temporal precision due to the long inter- survey intervals (e.g., 12-month) in which many smokers may make multiple quit attempts and vacillate between abstinence and smoking. Leveraging the nationally-representative longitudinal panel survey of US adults with 26 bi-weekly survey waves (April 2020 - July 2021) and nine additional monthly follow-up surveys (October 2021 - June 2022), this study aims to investigate short- and long-term prospective associations of time-varying nicotine vaping with time-lagged smoking abstinences in follow-up extending up to 110 weeks after baseline as well as mediational effects of anxiety/depression symptoms on vaping-related smoking cessation. The proposed study will address the fundamental questions of whether vaping encourages smokers to initiate and sustain smoking cessation in the real world, and if they experience cessation-related mental health benefits.